Bio-Layer Interferometry (BLI) Octet R8

Project Summary/Abstract
This proposal requests funding for an Octet R8 to support NIH Institutional Development Award
(IDeA) centers in the state of Nevada and NIH-funded researchers. A significant portion of the
instrument time would be to address the needs of NIH-funded investigators across the campus
via interdisciplinary collaborations and support between colleges of engineering, science, and
medicine. The Octet R8 will also provide support for the Nevada INBRE, Integrative
Neuroscience Center of Biomedical Research Excellence (COBRE) and the Cellular, Molecular
Imaging Center funded by NIH. The Octet R8 will allow researchers to perform new types of
biosensing, drug discovery, and diagnosis including protein-protein, protein-small molecule,
protein nanoparticles, and protein-DNA interaction studies in real-time and high-throughput
screening of potential therapeutics, and sensitive biomolecular sensing application.

Public health relevance
Project Narrative: The requested Biolayer Interferometry (BLI) Octet R8 instrumentation provides quantitative real- time detection of biomolecular in binding values. The Octet R8 is critically important to the continued success of current NIH funded research programs in Nevada that address fundamental questions related to diverse topics including; cancer, neurodegenerative diseases, infectious diseases such as viral and fungal infection mechanism and diagnosis, and understanding pre-term labor. The new instrument will also advance NIH efforts to support scientific research in underfunded states.